Targeting Myeloid Dependent MicroRNAs in Acute Respiratory Distress Syndrome

Abstract
Lung inflammation is one of the profound contributors to acute respiratory distress syndrome (ARDS). The
initial acute lung inflammation in response to infection or tissue injury leads to profound infiltration of leukocytes
and the release of inflammatory cytokines. Myeloid cells, including macrophages, are key players mediating
the onset and resolution of acute lung inflammation. However, the triggers that reprogram macrophages to
control excessive inflammation remain incompletely understood. Recent work has demonstrated a key role for
microRNAs (miRNAs) in inflammatory diseases. However, little research has been done to assess the
functional role of miRNAs in macrophages in the context of controlling lung inflammation. We hypothesize that
control of lung inflammation involves the transcriptional induction of specific miRNAs in macrophages. Our
study has identified microRNA-147 (miR-147) to be dramatically increased in recruited macrophages during
lung inflammation. The induction of miR-147 is dependent on hypoxia-inducible factor 1A. Functionally, miR-
147 controls macrophage inflammation in vitro, and myeloid-derived miR-147 dampens lung
inflammation in vivo. We identified and confirmed the mitochondria complex associated protein
NDUFA4 as a leading miR-147 target. New and exciting preliminary data indicated that by targeting
NDUFA4, miR-147 dampens the production of inflammatory cytokines such as IL-6, IL-1β, and TNFα in
macrophages. Additional evidence supports that inhibition of succinate oxidation and concomitant
histone hypermethylation contributes to the miR-147/NDUFA4 mediated effect. Finally, overexpression of
miR-147 improves the recovery from lung inflammation in vivo. Here, we test the hypothesis that the miR-
147/NDUFA4 axis represents an endogenous protective pathway in macrophages to control lung inflammation.
The following three aims have been proposed to test this hypothesis. In Aim 1, we will use state-of-art miR-
147 reporter mice to study the transcriptional regulation of miR-147 and investigate how miR-
147/NDUFA4 axis controls macrophage inflammation in vitro. In Aim 2, we will perform proof-of-principle
studies in human ARDS and employ cutting-edge transgenic mice to investigate the functional role of
miR-147/NDUFA4 axis in macrophages during lung inflammation in vivo. In Aim 3, we will further explore
the therapeutic targeting of miR-147/NDUFA4 axis in modulating lung inflammation. The completion of the
proposed study will identify miRNA targets as an innovative therapeutic approach for ARDS.

Public health relevance
Narrative Macrophages are crucial for the recovery from acute inflammation, however, the mechanisms that modulate macrophage function during this process remain unclear. This proposal tests the hypothesis that the induction of miR-147 in macrophages represents an endogenous protective pathway to control lung inflammation through suppression of its target NDUFA4. Our proposal addresses the urgent need to understand the mechanism of macrophage-mediated control of lung inflammation and facilitates the development of new therapeutic targets for acute respiratory distress syndrome.